Smart-phone-integrated, non-invasive, depth-resolved optical spectroscopy for the detection of neonatal jaundice

PROJECT SUMMARY
Newborns have immature liver function that is inefficient at metabolizing bilirubin. Consequently, nearly 80% of
preterm and 60% of term babies develop hyperbilirubinemia resulting in neonatal jaundice within a week of
their birth. As severe hyperbilirubinemia can be fatal, early, frequent and accurate monitoring of bilirubin is vital
to avoid severe health issues and determine appropriate treatment. The gold standard for detecting
hyperbilirubinemia is an invasive blood test to measure total serum bilirubin (TSB); however, frequent blood
sampling in neonates is costly, painful and increases the chance of infection. Existing non-invasive methods to
monitor hyperbilirubinemia lack sufficient accuracy to replace blood tests. Although commercial transcutaneous
bilirubinometry (TcB) is clinically accepted for jaundice screening, it has low correlation with TSB for clinical
decision-making in dark-skinned neonates and has low availability in low/middle income countries (LMICs).
A main reason for the limitation of TcB is spectral cross-talk: the inability to reliably distinguish
contributions between skin analytes (i.e., melanin) and blood. Our central hypothesis is that a non-invasive
mobile phone-based bilirubin detector can be developed that provides accurate, point-of-care blood bilirubin
measurements in dark-skinned neonates. We propose to use spectroscopic optical coherence tomography
(sOCT), an imaging technique those depth-resolved capabilities can overcome spectral cross-talk. In Aim 1 we
will develop portable, mobile phone-integrated sOCT for non-invasive, depth-resolved measurement of blood
spectra. Our working hypothesis is that depth-resolved, sOCT spectra of bilirubin correlate strongly with
spectral data from whole blood samples. Our innovative technical design will miniaturize and integrate
traditional sOCT components into a compact smartphone attachment. We will also develop a smartphone
application to perform data processing, analysis, display and HIPAA-compliant transmission or storage in lieu
of a bulky computer. In Aim 2 we will refine and test the sOCT algorithm in vivo. Our working hypothesis is that
sOCT measurements correlate better with lab-based TSB than does clinical TcB across a diverse range of skin
tones. In a clinical study of 100 neonates, we will compare sOCT data to the TSB blood tests and commercial
TcB. In Aim 3 we will validate the performance of sOCT in dark-skinned neonates from Kano, Nigeria. Our
working hypothesis is that sOCT performs comparably to lab-based TSB tests in dark-skinned neonates and is
acceptable for use in a LMIC setting. We will also assess potential challenges to incorporating sOCT into the
clinical workflow of a LMIC hospital. If successful, sOCT can provide an accurate alternative to commercial
TcB across diverse skin tones, including dark-skinned neonates and may potentially replace invasive methods
to detect and monitor hyperbilirubinemia in LMICs.

Public health relevance
PROJECT NARRATIVE Severe neonatal jaundice can be fatal and is a leading cause of death among newborns in many developing countries. The blood tests needed to detect severe jaundice are expensive and invasive, but non-invasive options have low accuracy in dark-skinned newborns. We propose to develop and clinically test the ability of a novel, non-invasive mobile phone-integrated device to provide accurate, point-of-care detection of jaundice in dark-skinned newborns.